Cognitive impairment in the DPPOS cohort and its neuropathologic, neurophysiologic, sociodemographic, and behavioral correlates

The goal of this project is to characterize the presence and correlates of cognitive decline, mild cognitive
impairment [MCI] and dementia in the Diabetes Prevention Program Outcomes Study (DPPOS) cohort.
Numerous epidemiologic studies have shown that pre-diabetes (PreD) and type 2 diabetes (T2D) are associated
with higher risk of cognitive impairment. However, gaps in knowledge remain about cognitive impairment in preD
and T2D: (a) What is the neuropathology other than vascular contributions to cognitive impairment and dementia
(VCID)? (b) Is neuronal insulin dysregulation present, and is it related to peripheral insulin resistance
characteristic of preD and T2D? (c) Do the associations differ by pertinent sociodemographics, including sex,
race/ethnicity, educational attainment, and literacy? (d) Are the associations related to behavioral correlates
(sleep disturbances and depressive symptoms), also common in preD and T2D? We will characterize amnestic
and non-amnestic cognitive decline, MCI, and dementia, in all participants (n =1979). We will measure plasma
biomarkers of amyloid (Aβ42/40 ratio), tau (ptau-181), neurodegeneration (neurofilament light [NfL]), and
neuroinflammation (glial fibrillary acidic protein [GFAP]) in all participants, and brain imaging markers of amyloid,
neurodegeneration (cortical thickness), cerebrovascular disease (white matter hyperintensities [WMH] and
infarcts), white matter microstructure, and functional connectivity, in a subsample of 650 participants. We will
characterize the AD continuum and non-AD pathologic change using plasma ptau-181 and Amyloid Positron
Emission Tomography (PET), following the National Institute on Aging (NIA)/Alzheimer’s Association (AA)
research framework, and will explore characterization by tau, neurodegeneration, neuroinflammation, and VCID.
We will isolate total circulating extracellular vesicles (EVs) and neuronal origin-enriched EVs (nEVs) in all
participants once to examine systemic and neuronal insulin signaling. We will achieve our goal through the
following specific aims: (1) To examine the prevalence and incidence of amnestic and non-amnestic cognitive
decline, MCI and dementia, and examine their association with biomarkers of amyloid, tau, neurodegeneration,
neuroinflammation, and with VCID; (2) To examine the association of cognitive syndromes with systemic and
neuronal insulin signaling measured using nEVs. (3) To examine the association of sociodemographic factors
including sex, race/ethnicity, education, and literacy, with cognitive decline, MCI, and dementia, and
neuropathology biomarkers; (4) To explore the association of depressive symptoms, sleep quality, and
obstructive sleep apnea with cognitive decline, MCI, and dementia. We will also explore their association with
biomarkers of neuropathology. We will also explore (a) whether neuronal insulin signaling is related to peripheral
metabolic measures collaborating with Project 2; (b) whether findings in aims 1 and 2 vary by use of T2D
medications collaborating with Project 3; (c) the physical correlates of cognitive syndromes collaborating with
Project 4.